T cell surveillance of senescent cells under homeostasis and aging

PROJECT SUMMARY/ABSTRACT
RESEARCH: Aging is the single greatest risk factor for a multitude of morbidities. While multifactorial, a central
mechanism of aging is cellular senescence, a complex, context-dependent cell fate with important roles in both,
physiological and pathological processes. The acute generation and subsequent elimination of senescent cells
is usually a physiological, beneficial process associated with accelerated tissue regeneration after injury, but the
aberrant senescent cell accumulation is linked to a wide range of pathologies, morbidities, and shortened healthy
life spans in mice. The mechanisms governing physiological senescent cell elimination, or their pathological
accumulation with age are incompletely understood, particularly in the human context. T cells have emerged as
one of the crucial players in controlling and killing senescent cells, however, how senescent cells engage and
activate T cells to elicit T cell activities and cytotoxicity is largely elusive. In this proposal, I investigate molecular
mechanisms of T cell-mediated surveillance of senescent cells under both physiological and aging conditions.
In Aim 1, I will define how various types of senescent cells deploy their secretome to sensitize human T cells
toward activation, survival, and retention. Aim 2 will assess co-stimulatory and co-inhibitory interactions between
senescent cells and T cells, crucial prerequisites of effective T cell activity or inhibition. In Aim 3, I will perform
translational studies in human kidney specimens to elucidate spatially resolved T cell surveillance of renal
senescent cells as well as mechanistic studies in isolated primary renal cells.
CANDIDATE: This proposal integrates my Ph.D. expertise in cellular senescence with my post-doctoral work on
T cell aging and allows me to build an independent, unique research niche. However, to realize this goal, I require
additional protected time and new research and professional skills. Here, I describe a detailed plan for my
transition to independence. The research during the K99 phase will be conducted at Mayo Clinic, the world’s
top-ranked hospital and an ideal institution for translational, human research on aging. The objectives of this
proposal are to i) gain additional mentored research and career training to build an independent translational
research program dedicated to age-related T cell dysfunction contributing to pathological senescent cell
accumulation in humans; ii) perform a series of experiments to uncover molecular mechanisms of T cell
engagement by senescent cells under optimal conditions and delineate the impact of T cell aging on senescent
cell immune evasion. Completion of the proposed aims allows me to build a strong foundation on T cell
surveillance of senescent cells enabling me to discover key mechanisms of senescent cell immune escape. This
will leave me well-positioned to become an independent investigator, securing competitive funding, advancing
the field of senescence immunosurveillance, and contributing towards my long-term research goal of promoting
healthy aging through the development of immunotherapies targeting pathological senescent cells.

Public health relevance
PROJECT NARRATIVE Age-associated changes in T cells compromise their functionality and render older adults vulnerable to infections and age-related diseases, yet it remains unclear how T cells and their age-related dysfunction contribute to senescent cell accumulation. The overarching goal of this project is to 1) investigate how senescent cells stimulate T cell-mediated surveillance under physiological conditions, and 2) explore how T cell aging facilitates senescent cell immune evasion resulting in pathological senescent cell accumulation with human aging and disease. Discoveries from these studies will contribute to the development of immunotherapies for the elimination of pathological senescent cells, thereby supporting healthy aging.